Single cell multiomic characterization of the diverse spectrum of Alzheimer's disease across the brain.

ABSTRACT (PROJECT 2)
Recent advances in single nucleus genomics have enabled high-resolution characterization of molecular and cellular
diversity in the human brain. The Seattle Alzheimer’s Disease Brain Cell Atlas (SEA-AD1.0) established best tissue
preservation practices for high quality genomics assays and developed an effective strategy for applying genomics
techniques to tissues from aged individuals with varying Alzheimer’s disease (AD) neuropathological burden, producing a
detailed model of disease severity and characterization of vulnerable and disease-associated cell types in multiple brain
regions affected by AD. Using integrated quantitative neuropathology and single nucleus genomics SEA-AD1.0 identified
disease pseudo-progression trajectories and molecular pathways dysregulated in AD. However, many brain regions
impacted by AD remain to be studied, particularly subcortical regions that are among the earliest to show substantial
accumulation of AD neuropathologic proteins and widespread neuronal loss with disease progression. Furthermore, most
single nucleus genomics studies have been conducted in predominantly non-Hispanic Caucasian populations, despite
evidence that disease risk modifying loci can vary among ethnic backgrounds. Likewise, heterogeneity in disease
progression resulting from comorbid pathologies and distinct AD subtypes remains to be explored at the cellular level.
In SEA-AD2.0, we will apply our genomics-based strategy to interrogate cellular and molecular changes occurring across
the brain in donors spanning the spectrum of AD pathology (AD Spectrum), and in a larger, more diverse cohort that
encompasses AD and prevalent comorbid dementias (AD and AD/ADRD Spectrum). Multiome (parallel transcriptomic and
epigenetic profiling) will be applied in SEA-AD2.0 to target cell type level changes in both gene expression and epigenetic
states in relationship to AD and AD/ADRD pathology and disease diagnosis. To characterize brain-wide impacts of AD
pathology and determine cellular and molecular changes that occur at the earliest stages of disease prior to the onset of
cognitive symptoms, we will sample subcortical regions with early AD pathology, such as cholinergic neurons in the Basal
Nucleus of Meynert, and regions of the Default Mode Network that are affected early and whose functions are
progressively impacted with increasing AD neuropathological burden in a large cohort of AD Spectrum donors (n=100). To
understand variation in cellular and molecular disease signatures across common AD/ADRD co-pathologies, topological
and cognitive AD subtypes, sexes, and diverse demographic populations we will analyze a core set of brain regions that
span early to late affected areas in an expanded cohort of AD/ADRD Spectrum donors (n=300) with targeted sampling
across these axes of diversity to ensure adequate statistical power to test for commonalities and differences between
groups. The resulting data will enable identification of shared and brain region-specific vulnerable and disease associated
cell types, direct interrogation of dysregulated gene networks in affected cell types, and comparison of cellular and
molecular changes in a diverse donor cohort. All data produced in this project will be made publicly accessible.

Public health relevance
PROJECT NARRATIVE (PROJECT 2) Alzheimer’s disease (AD) is a prevalent and progressive neurodegenerative condition that has widespread cellular impacts in the brain and is often accompanied by other comorbid pathologies. The initial phase of SEA-AD established a robust platform for high quality single nucleus genomics analyses and detailed characterization of cellular changes across multiple brain regions impacted by AD, revealing cell type-specific vulnerabilities and disease-related changes in molecular programs. The present proposal extends this work to new brain regions involved in very early AD pathology and to a racially and ethnically diverse cohort with AD and prevalent comorbid pathologies (ADRD) to examine the impacts of disease pathology occurring prior to the onset of clinical symptoms and cognitive decline and to characterize cellular and molecular changes associated with AD that are common and variable across brain regions, sexes, races, and co- pathologies.